Spermatogonial stem cell transplantation and culture in patients

ABSTRACT
Medical treatments for cancer or other conditions can cause infertility. Sperm cryopreservation is an effective
option for adult men to preserve their fertility. This option, however, is not available to prepubertal boys who
are not yet producing sperm. For over 20 years, centers around the world have been cryopreserving immature
testicular tissues, which contain spermatogonial stem cells, for boys in anticipation that the tissues or cells can
be matured in the future to produce sperm. Some of those survivors are now returning to use their tissues for
reproduction. SSC transplantation and testicular tissue grafting are mature technologies that are ready for
translation to the human clinic. At the University of Pittsburgh Medical Center, we are approved to deploy these
technologies for patients who previously cryopreserved their testicular tissues.
In the proposed research, we will test the safety and feasibility of transplanting human SSCs (hSSCs) or
grafting testicular tissues back into human patients. We note, however, that technical challenges exist that limit
transplant efficiency or the deployment of these technologies to all patients. First, autologous transplantation in
patients with testicular or blood-borne cancers or neuroblastomas may risk re-introducing malignant cells.
Second, testis biopsies from young boys are small and may contain a small number of SSCs. There is a broad
consensus that we will need to propagate hSSCs ex vivo for robust regeneration of spermatogenesis upon
transplantation. Long-term cultures that lead to SSC propagation are well established in mice, but its
translation to hSSCs has been limited. The proposed research will develop multi-parameter sorting strategies
to enrich human testis cell fractions with hSSC transplantation while removing contaminating somatic cells that
can overgrow cultures and malignant cells that would be unsafe to transplant back into the patient. We will test
the hypothesis that sorted human testis cell fractions with the greatest transplantation potential also have the
best culture initiating potential as seen in mice. In addition, we will test the impact of donor age on hSSC
culture starts as well as the impact of growth factors or other compounds, oxygen concentration, feeder cells
and extracellular matrix substrates (ECM). Our multidisciplinary team has patients who are ready for first in
human transplant procedures, testicular tissues from all ages of development, bioinformatic data that suggest
potential ligands to test in hSSC culture and decellularized pig and human testis ECM substrates. Collectively,
our efforts will test and improve the safety and feasibility of testicular cell/tissue transplant procedures in
patients and establish robust, reproducible methods to maintain and expand hSSCs in culture.

Public health relevance
PROJECT NARATIVE Thousands of patients worldwide have cryopreserved their immature testicular tissues with anticipation that spermatogonial stem cells (SSCs) in those tissues can be thawed in the future and matured to produce sperm. We are poised to perform the first SSC transplantation and testicular tissue transplantation procedures in patients who previously cryopreserved their tissues. To expand the impact of those technologies, we will develop cell sorting strategies to enrich SSCs and remove contaminating malignant cells and develop methods to expand human SSC numbers in culture to advance fundamental investigations and expand potential applications in patients.